Novel Therapeutics Against Diabetic Eye Disease

Project Summary/Abstract Diabetes mellitus is recognized as a leading cause of new cases of blindness among Americans between the ages of 20 and 74. The prevalence of diabetic eye disease is expected to continue to increase in the American population and worldwide as a result of the dramatic increase in the number of people with diabetes. At present, there is no medical treatment to delay or prevent the onset and progression of cataract or retinopathy, the most common causes of vision loss in diabetics. We propose a study organized around two specific aims to develop novel therapeutic compounds identified from extracts of the Indian gooseberry plant Emblica officinalis. These natural compounds have activity as aldose reductase inhibitors and show promise as agents to suppress metabolic abnormalities associated with the onset and progression of diabetic cataract and retinopathy. In aim 1, we will purify sufficient quantities of the lead compounds to conduct toxicity studies using lens and retinal pigment epithelium tissue culture systems. We will examine the efficacy of lead compounds against cataract formation in our human aldose reductase transgenic mouse model. Studies will also be carried out to evaluate the ability of lead compounds to suppress markers of inflammation in a diabetic mouse model. In specific aim 2, we will use molecular modeling to design novel derivatives to enhance binding affinity and specificity. Derivatives will be synthesized and evaluated for efficacy in tissue culture and animal model systems. We will examine interactions between optimized compounds and human aldose reductase by steady- state kinetics. Binding specificity will be examined using several members of the aldo-keto reductase gene superfamily.

Public health relevance
Project Narrative Diabetes mellitus is a leading cause of new cases of blindness among Americans between the ages of 20 and 74. The proposed research seeks to discover naturally occurring compounds that delay or reduce the progression of diabetic cataract and retinopathy. Novel therapeutics will be designed from natural lead compounds and will be optimized to enhance efficacy against diabetes-induced vision loss.! __SpecificAimsTextDelimiter__ Specific Aims Diabetes mellitus is recognized as a leading cause of new cases of blindness among Americans between the ages of 20 and 74. At least 5,000 new cases of legal blindness result each year from diabetic retinopathy alone. In comparison with the general population, diabetic patients face a 25-fold increased risk of blindness as a result of diabetic retinopathy and/or cataract. While strict long-term control of blood glucose can reduce the likelihood of developing retinal lesions leading to retinopathy, present methods for achieving strict metabolic control are personally demanding, potentially cost prohibitive, and are not completely effective. Therefore, patient education, lifestyle modifications, and new technologies such as blood glucose monitors and insulin pumps will still be ineffective at preventing diabetic eye disease for the general population. Numerous trials and experimental animal studies have shown that early intervention is required to achieve maximal reduction in the onset and severity of diabetic retinopathy. Medical therapies to stall the onset and progression of retinopathy must be sufficiently safe and well tolerated to allow lifelong treatment for patients at risk for diabetic eye disease. Several therapeutic strategies have been pursued but ultimately failed in clinical trials against diabetic retinopathy. Early trials involving the first generation of aldose reductase inhibitors were plagued by poor trial design, toxicity issues related to spirohydantoin-based inhibitors, and poor inhibitor penetration of the blood- retina or blood-brain barriers. Despite compelling preclinical data from animal studies, drugs developed to target PCK-β or advanced glycation endproducts were also unsuccessful in clinical trials against endpoints for diabetic retinopathy. Given the dearth of new therapeutic strategies to delay or prevent diabetic complications in the eye, and the inexorable rise in the prevalence of diabetes worldwide, we propose that natural products offer a large and essentially untapped resource for the purpose of medicinal use. Accordingly, we have turned to natural product pharmacophores as a source of new lead compounds against diabetic eye disease. We recently discovered that materials in fruits of the Indian gooseberry plant offer significant protection against cataract in a diabetic rat model. We have identified the therapeutic pharmacophore from this traditional medicine that inhibits aldose reductase. As the action this enzyme has been linked to the pathogenesis of diabetic complications such as cataract, retinopathy and neuropathy, it has considerable potential as a therapeutic target to delay or prevent diabetic eye disease. We propose studies to investigate the efficacy of a series of novel natural products identified in extracts from the Indian gooseberry plant (Emblica officinalis). We show in preliminary studies that the lead compound has desirable properties against diabetic cataracts in two different animal models. Further, enzyme kinetic studies demonstrate binding to human aldose reductase, which correlates with molecular docking studies based on the atomic structure of the enzyme. Our study is organized around 2 specific aims, as follows. Specific Aim 1: Test the hypothesis that natural products in fruits of Emblica officinalis can be optimized as inhibitors of diabetic eye disease. We will identify and characterize materials extracted from Emblica fruits as inhibitors of diabetic cataract and retinopathy. This will be accomplished using a variety of tissue culture systems and 2 transgenic animal models that have phenotypes relevant to diabetic eye disease. We will also examine the ability of these compounds to suppress the activation of pro-inflammatory markers associated with diabetic retinopathy in an animal model. Specific Aim 2: Rationally design, synthesize, and characterize a series of novel derivatives based off the lead pharmacophore isolated from Emblica officinalis. We have identified a novel pharmacophore through bioassay-guided isolation that displays potent in vitro activity against human aldose reductase. Using structure based drug design, through molecular modeling studies, with human aldose reductase, we have identified a series of derivatives that are predicted to demonstrate enhanced affinity and specificity to human aldose reductase. These compounds will be synthesized and tested in our tissue culture and animal models for efficacy against markers of diabetic eye disease. Affinity and specificity toward human aldose reductase will be assessed by steady state enzyme kinetic studies. Our study will be co-directed by 2 Principal Investigators with expertise in diabetic cataract and retinopathy and natural product medicinal chemistry, respectively. This innovative partnership will lead to far more progress toward discovery and validation of novel therapeutic agents than either group could accomplish individually.